Systems Biology Approach to the Management of Chronic Kidney Disease-Mineral Bone Disorder

The derangements of mineral metabolism that accompany chronic kidney disease (CKD) greatly
increase the risk of cardiovascular mortality. Veterans suffer from CKD and the cardiovascular
consequences disproportionately compared to the general population. Amelioration of the
biochemical abnormalities, specifically phosphate (Pi), calcium (Ca), and parathyroid hormone (PTH)
is associated with superior survival in dialysis patients; however, only a minority of patients can
achieve and sustain the levels proposed by Kidney Disease: Improving Global Outcomes (KDIGO)
guidelines. The major barriers are the complexity and individual diversity of CKD-MBD and the
heterogeneity in individual response to therapy. We have developed and validated a systems biology
model encompassing both measurable (serum Ca, Pi, and PTH) as well as non-measurable, clinically
relevant parameters of mineral metabolism such as loss of bone mineral and vascular calcification.
Applying artificial intelligence techniques of reinforcement learning in combination with our model,
we have determined that standard therapeutic approaches targeting Pi, Ca, and PTH may not result in
optimal control of the pathophysiologic processes that result in morbidity and mortality.
These results suggested two hypotheses to be tested in this proposal. Hypothesis 1: Based on
individual biochemical and mineral flux responses to therapy, we can identify phenotypic subsets of
CKD-MBD whose courses of disease are distinct, and which mandate different therapeutic
approaches. Hypothesis 2: Targeting the abnormal fluxes of mineral, out of bone and into the
vascular smooth muscle, will lead to significant refinements in the therapy of CKD-MBD for the
individual by incorporating the degree of bone turnover into the recommendations for achieving
KDIGO guidelines for biochemical parameters.
We will address these hypotheses through the following aims:
Aim 1. Obtain human data on non-routinely measured markers of mineral metabolism and
cardiovascular health within CKD-MBD.
Aim 2. Enhance the Systems Biology Model of CKD-MBD with additional markers of mineral
metabolism.
Aim 3. Develop Systems Biology guided treatment regimen to CKD-MBD based on clinical end points.
Aim 4. Validate treatment regimen for physician’s acceptance using Physician-in-the-Loop approach.
This innovative and highly translational approach will advance the over-arching goal of this project to
improve clinical outcomes for Veterans with CKD-MBD through the application of personalized
therapeutics. The use of large Veteran databases to develop personalized medical therapy for complex
disease, exemplified in this application, is a priority for the Department of Veterans Affairs.

Public health relevance
Veterans with Chronic Kidney Disease (CKD) suffer accelerated cardiovascular disease, accelerated loss of bone, and premature mortality despite adequate control of blood pressure and blood chemistries. CKD incidence and prevalence are risking, with estimates of cost to the VA in excess of $19 billion. The causes and clinical manifestations of kidney disease are highly variable, yet clinicians have been approaching all patients uniformly. Development of clinical tools that could both identify Veterans at high risk for bone and cardiovascular complications and recommend personalized therapies for them would be of great clinical benefit. The modeling system to be implemented in this proposal addresses the complex aspects of the clinical manifestations and the multi-drug therapies required to achieve clinically relevant outcomes including preservation of bone mineral and decreased cardiovascular risk.